Physiological Role of the Vitamin A Transporter RBPR2 for Vision

Summary: Distribution of dietary vitamin A/all-trans retinol/ROL throughout the body is critical to maintain
retinoid function in peripheral tissues and to ensure optimal vision. In humans, dietary vitamin A is absorbed in
the small intestine, stored in the liver, and secreted into circulation bound to serum retinol binding protein 4
(RBP4-ROL). A receptor-mediated system for systemic RBP4-ROL uptake, storage and transport is essential
not only to ensure availability for optimal ocular retinoid signaling for photoreceptor function, but also to prevent
cellular toxicity associated with excessive retinoid accumulation. STRA6, the only known receptor for circulatory
ROL bound RBP4 in the eye, is not expressed in systemic tissues proposed to facilitate the uptake of RBP4-
ROL. This indicates the existence of additional vitamin A transporters in such tissues. The objectives of this
proposal are 1] to determine the physiological role a novel vitamin A transporter, the retinol binding protein 4
receptor 2 (RBPR2) in facilitating the systemic uptake of dietary ROL bound RBP4 for vision, and 2] to investigate
if modulation of such eye related ROL transporters could limit substrate availability required for toxic retinoid
biogenesis and thus improve vision in patients with inherited retinal degenerative diseases. The long-term goal
is to identify the physiological mechanisms of RBPR2 for RBP4 binding and ROL transport in retinal health and
disease states. The central hypothesis is that RBPR2 has high affinity binding for RBP4-ROL in tissues devoid
of STRA6 and that its physiological function is critical to ensure and regulate dietary vitamin A uptake and delivery
to the eye in the support of vision. The rationale underlying this proposal is that completion will fill the knowledge
gap of how dietary vitamin A is sequestered into systemic tissues from RBP4, transported and stored in
peripheral tissues lacking STRA6, for eventual distribution to the eye for vision. The central hypothesis will be
tested by pursuing three specific aims that will in Specific Aim 1: Determine the functionality of RBPR2 for
vitamin A transport; Specific Aim 2: Determine the physiological role of RBPR2 for systemic RBP4-ROL
transport in vision; and Specific Aim 3: Determine if modulation of Rbpr2 activity attenuates inherited retinal
degenerative diseases. We will pursue these aims using an innovative combination of structural analysis,
biochemistry, cell biology, physiology and novel animal models aimed at exploring the in vivo requirements of
RBPR2 for ROL transport for photoreceptor health, vision and in retinal disease. The proposed research is
significant because it will determine for the first time the mechanisms influencing circulatory RBP4-ROL uptake,
storage and transport into the eye, and explore strategies aimed at modulation of such eye related ROL-
transporters for improving vision in humans with inherited retinal diseases. The proximate outcome of the
proposed research will provide information on a novel ROL transporter, RBPR2, that will improve understanding
of human disease states, particularly blindness, associated with impaired blood vitamin A homeostasis or ocular
vitamin A excess and could yield concepts for their prevention and therapy.

Public health relevance
PUBLIC HEALTH NARRATIVE In humans, either prolonged dietary vitamin A deficiency (VAD) or inherited mutations in retinoid/visual cycle genes manifests in similar retinal degenerative phenotypes, eventually leading to vision loss and blindness. This study proposes to test the novel hypothesis that the retinol binding protein receptor 2 (RBPR2) facilitates and regulates dietary vitamin A transport and hence physiologically plays an important role in photoreceptor health and vision. At the completion of this project, a mechanistic understanding of RBPR2 function for ocular vitamin A homeostasis will help design strategies aimed at modulation of such eye-related ROL transporters for improving vision in humans with inherited retinal diseases.